Renewal of the Human Islet Research Enhancement Center (HIREC) for the Type-1-Diabetes-Focused Human Islet Research Network (HIRN).

ABSTRACT
The scale and scope of scientific collaborations in the Human Islet Research Network (HIRN)
bring together extraordinary resources to solve complex problems in type 1 diabetes (T1D). To
capitalize on this initiative, extensive efforts are required to coordinate, communicate, and
catalyze research effectively. The City of Hope is applying to renew the Human Islet Research
Enhancement Center (HIREC), providing the administrative and scientific infrastructure needed
for day-to-day operations of the HIRN and capitalizing on existing and emerging resources to
propel it forward as an innovative team science engine in T1D research. The specific aims of this
project were formed to address critical challenges and requirements, or put simply to engineer,
enrich, and empower the future of HIRN. The established team is not only experienced in
establishing data centers, systems, and resource distribution networks critical to the HIRN, but
also are researchers with expertise in T1D disease pathogenesis, biostatistics, bioinformatics,
computational biology, data science, semantic technologies, software development, and the use
of Findable, Accessible, Interoperable, and Reusable (FAIR) principles. Discoveries arising from
HIRN will profoundly improve our understanding of T1D pathogenesis and expedite the
advancement of disease prevention and treatment strategies.

Public health relevance
PROJECT NARRATIVE The scale and scope of scientific collaborations in the Human Islet Research Network (HIRN) bring together extraordinary resources to solve complex problems in type 1 diabetes (T1D). To capitalize on this initiative, extensive efforts are required to coordinate, communicate, and catalyze research effectively. This proposal to renew the Human Islet Research Enhancement Center (HIREC) provides the infrastructure and environment needed to accelerate progress and success in HIRN, transforming discoveries into strategies that prevent and/or treat T1D.